Anti-inflammatory microbiome-substrate-host interactions

SUMMARY
Inter-individual variability in host-microbiome interactions contributing to inconsistent results in human
clinical studies, presents a major hurdle in determining efficacy and intake recommendations for dietary
polyphenols. Gallotannins and other gallated phenolics are present in fruits, spices, and teas, and represent a
significant portion of human polyphenol intake. Gallotannins are non-absorbable polymerized gallates that are
hydrolyzed and metabolized by the colonic microbiota to gallic acid (GA) and pyrogallol (PG) as primary microbial
metabolites. Gut microbial metabolism is a poorly defined determinant of polyphenol pharmacokinetics (PK) and
is characterized by inter-individual variability. Preliminary data indicate that: (i) Lactobacillus plantarum (L.
plantarum) converts gallotannins to free, absorbable GA and PG; (ii) sulfated and methylated metabolites of GA
and PG are readily detected in plasma, urine, and feces of healthy humans after consumption of gallotannins;
(iii) PG and its metabolites exhibit potent anti-inflammatory activities both in vitro and in vivo and in human clinical
pilot studies; and (iv) metabolism of tannins/gallates is associated with decreased endotoxin and increased short-
chain fatty acid (SCFA) production. Central Hypothesis: Inter-individual differential microbial metabolism of GTs
into GA and PG is a significant determinant of their anti-inflammatory efficacy in intestinal inflammation. Three
integrated specific aims will be pursued as follows: Aim 1 Elucidate GT metabolism in genetic Lp variants and
anti-inflammatory signatures in intestinal organoids in vitro using engineered L. plantarum (Lp) strains, including
wildtype (LpWT), gallotannase (LpTAN) and gallate decarboxylase (LpDCX-) knockouts, and a double-knockout
(LpTAN-/DCX-). Aim 2 Evaluate GT-metabolite signatures within isolated intestinal microbial environments in
vivo by applying targeted and unbiased LC-MSn-metabolomics, meta-genomic, and transcriptomic profiling as
well as pharmacokinetics in a gnotobiotic mouse model treated with Lp-variants and GTs. Aim 3 Assess
pharmacokinetic GT-metabolite signatures and their anti-inflammatory signatures within human intestinal
microbial environment as well as microbial adaptation to GTs via targeted meta-genomic, -transcriptomic, and
metabolomic analysis in human feces (ulcerative colitis (UC) and controls) +/- LpWT, in mini-bioreactor arrays
and in an Mdr1a KO mouse model +/- LpWT stably associated with UC and healthy human fecal microbiota.
The host-microbiome-metabolite nexus represents a critical missing link in human clinical trials. Completion of
Aims 1-3 will provide a better understanding of causal relationships in the cross-talk between dietary polyphenol
intake, and L. plantarum as a probiotic component of the microbiome.

Public health relevance
PROJECT NARRATIVE Complex polyphenols in the human diet have anti-inflammatory benefits relevant to intestinal inflammation. However, a critical missing link in our current understanding of this area involves the role of gut bacteria and their metabolites, generated locally in the gut, following consumption of polyphenol-rich foods. The proposed research focuses on novel bioactive compounds in mango, and the crosstalk that exists between the gut microbiome and host metabolizing pathways that regulate local and systemic anti- inflammatory actions.